Characterizing the interpretation and generation of Erk signaling dynamics using high-throughput genetics

PROJECT SUMMARY
Cells reuse the same signaling pathways to initiate differing responses and distinct cell fates. This plasticity in
cellular decision-making is crucial in biological contexts ranging from development to cancer biology, where
identical cells may acquire distinct properties such as differentiated cell fates or drug resistance phenotypes.
The Erk pathway is responsible for heterogeneous fate decisions in many biological contexts. Recent studies
have uncovered two potential sources of heterogeneity in Erk signaling. First, different cells may have different
Erk signaling dynamics, ranging from constant high or low signaling states to repetitive pulses of Erk kinase
activity. Second, even a uniform field of Erk-active cells do not all transcribe canonical downstream target genes.
Connecting single-cell behavior to a multitude of distinct cellular responses and cell fates requires an
understanding of the molecular mechanisms generating pathway dynamics and interpreting pathway activity into
a transcriptional response. Here, we propose to identify molecular drivers for heterogeneity in Erk-induced
responses using genomic methods, and a novel Erk biosensor: the Recorder of Erk Activity Dynamics, or
READer. READer selectively transcribes GFP only in response to pulses of Erk activation, allowing for rapid and
high-throughput identification of cells that have both undergone an Erk pulse and initiated immediate-early gene
transcription. In this proposed work, the READer system will be paired with live-cell imaging, RNA
sequencing and scalable CRISPR screening technologies to 1) investigate cell states mediating Erk
response and 2) dissect the molecular mechanisms responsible for Erk pulse generation and regulation.
Together, these data will provide key insights into how differences in single-cells can arise, and how this
heterogeneity effects signaling outcomes. Understanding the origins and consequences of heterogeneity is
crucial to our understanding of development and cancer biology, as well as for the development of novel cell-
based therapeutics, which require precise control of engineered cell fates for clinical applications.
The proposed work will take place at Princeton University in the Department of Molecular Biology under the
direct supervision of sponsor Dr. Jared Toettcher and co-sponsor Dr. Britt Adamson. The sponsors’ laboratories,
the departmental community and Princeton’s overall graduate program provide an excellent supportive
environment for the proposed project to succeed. Princeton University has stellar core facilities and resources
available and accessible to the fellow that will enable efficient, high-quality and thorough research-training and
data collection. The training plan will enable the fellow to develop skills in next-generation sequencing analysis,
live-cell imaging, and synthetic biology, as well as supporting her growth and development in mentorship and
scientific communication.

Public health relevance
PROJECT NARRATIVE The development of single-cell Erk biosensors and single-cell RNA sequencing has revealed that Erk activity is heterogeneous: both in transcriptional activity and temporally, with some cells exhibiting complex Erk-signaling dynamics. Using novel biosensors, high-resolution live-imaging, 3D models of mammalian development, and scalable CRISPR-screening approaches, this work proposes to interrogate how single-cells integrate Erk activity and gene-expression programs, in addition to addressing the mechanisms that generate single-cell Erk signaling dynamics. Erk signaling is responsible for many cellular decisions, including the evolution of drug-resistant cancer cells, therefore an understanding of the precise behavior and regulation of Erk activity at the single-cell level will directly inform chemotherapeutic drug development.